Dev-Core-001

DEVELOPMENT CORE: PROJECT SUMMARY
The Development Core (DC) is the central research and innovation hub of the PSC. Its overarching objective is
to promote the professional activities, intellectual exchanges, and academic ties, including access to financial
support, that generate an environment that enhances the production of innovative and high-impact research in
our five Primary Research Areas (PRAs): New Dynamics of Population Diversity, Formal Demography and
Demographic Methods, Child Development and Human Endowments, Structures of Inequality and the Life
Course, and Population and the Environment. The specific aims of the DC are to: 1) recruit and mentor junior
scientists to produce innovative, high-impact population science research in our PRAs and foster their growth
via a dedicated mentoring program, and career and grant writing workshops; 2) administer, oversee, and
promote activities that foster innovative, interdisciplinary, and high-impact population science, including a
weekly colloquium, special conferences and events, research workshops, and grant writing and career
workshops; 3) administer, oversee, and promote the Quartet Pilot Research Project Competition in
collaboration with the Population Aging and Research Center (PARC), Center for Health Initiatives and
Behavioral Economics (CHIBE), and Boettner Center for Financial Gerontology, and link research associates
to other sources of support at Penn to increase competitiveness for peer-reviewed external funding in
population research, especially among junior scientists.; and 4) administer, oversee, and promote PSC's
partnerships and outreach initiatives. These activities include partnerships with international collaborators and
Temple University's Public Policy Lab; sponsorship of the Philadelphia Federal Statistical Research Data
Center (FSRDC); and a new sponsored research affiliation program.